The Atlantic Health Cancer Consortium Community Oncology Research Program (AHCC CORP)

Project Summary
Atlantic Health Cancer Consortium Community Oncology Research Program (AHCC-CORP) is the first
NCORP Community Site within the state of New Jersey and combines the collective strengths of world-class
healthcare systems with community oncology care delivery. AHCC-CORP covers a geographically and
demographically diverse area representing 73% of New Jersey’s population. AHCC-CORP expands the
NCORP network by 6.5M people; with a higher cancer incidence rate than the US as a whole (477.5 vs 441.2
cases per 100,000). Regions of AHCC-CORP are even further elevated.
Specific Aims include: ​1) Increase adult and pediatric accruals to NCI cancer prevention, control,
screening, and care delivery research studies, as well as treatment and imaging studies conducted by
the National Clinical Trials Network (NCTN) and biospecimen collection​. ​This will be accomplished by
creating a unique and unprecedented cancer care consortium in New Jersey​. ​The Consortium has experienced
cancer investigators in adult and pediatric cancers across multiple sites, including three children's hospitals.
Separately, Consortium sites annually accrue an average of 130 ​participants to NCORP Research Bases, but
with the leadership and infrastructure support of AHCC-CORP, affiliates are now poised to even further
increase accruals. ​2) Enhance community engagement in ​cancer control and prevention clinical trials
and Cancer Care Delivery Research (CCDR) conducted by NCORP ​in the AHCC-CORP ​catchment area.
Engagement will be enhanced through innovative approaches that effectively engage physicians, patients, and
the community. Developments ​notably include video vignettes for social media dissemination and interactive
chatbot capabilities powered by natural language processing, allowing recruitment/retention strategies in
multiple languages in support of cancer disparities integration. Additionally, AHCC-CORP ​has a clearly-defined
process for prioritizing NCORP and NCTN trials for activation, and procedures in support of successful study
accrual and data collection across sites.​ AHCC-CORP will also support and mentor community oncologists and
other medical specialists in central and northern New Jersey​, furthering capabilities in cancer care delivery
research. ​3) Contribute to the development and implementation of clinically significant studies that
incorporate the unique research needs of the diverse population within the AHCC NCORP catchment
area, leveraging the expertise of established oncology specialty physicians and other providers within
our affiliate network. ​The established clinical and research expertise, across multiple tumor types and
research modalities, of AHCC-CORP physicians and other providers will be leveraged to support NCORP
overarching programmatic goals through ​active involvement in Research Bases and other NCORP-wide
research leadership committees.

Public health relevance
Project Narrative As the first NCORP Community Site in the state, AHCC CORP serves three-quarters of the New Jersey population across a diverse range of demographics. AHCC CORP expands the NCORP network by 6.5M people, advancing the state of the science in cancer prevention, control, screening, care delivery research, and precision medicine studies through biospecimen collection, as well as providing critical access to treatment and imaging studies conducted by the National Clinical Trials Network. With a higher cancer incidence rate than the US as a whole, New Jersey is an underrepresented area for cancer prevention and control research.